EFFECT OF NORETHINDRONE MICROSPHERES ON PITUITARY GONADOTROPIN PULSATILITY (HUMAN

The purpose of this project is to evaluate the effect of 65mg and 100 mg net microspheres on hypothalamic and pituitary function, specifically LH pulsatility.